CSHL Course on Proteomics (2025-2029)

Abstract
CSHL Proteomics Course
The proposed Cold Spring Harbor Laboratory Course on Proteomics is to be held each summer
from 2025 through 2029. Proteomics is one of the pillar technologies of systems biology by which
hundreds or thousands of proteins can be monitored and characterized simultaneously. In combination
with genomics and metabolomics, proteomics is an enabling core technology to probe biological
activities in parallel, providing unprecedented analytical insight into diverse biological processes in
mammalian development and disease. Models of many human diseases have been developed in a
wide variety of animal systems, in particular vertebrate models such as mouse, zebrafish, rat and frog,
and invertebrate models such as worms and flies; and increasingly the use of new stem cell
technologies is being harnessed to produce powerful in vitro models to be deployed alongside animal
models. There is a growing need for implementation of systems biology approaches to these models,
which necessitates an in-depth understanding of the challenges and pitfalls of various “high-throughput”
technologies, achieved in part by hands-on and highly focused training.
This intensive two week laboratory and lecture course will focus on cutting-edge proteomics
approaches and technologies. Students will be trained in experimental design and sample preparation,
they will acquire high-sensitivity liquid chromatography tandem mass spectrometry (LC-MS/MS) data,
and will be taught how to reliably interpret this data at both the level of identification and quantification.
Students will gain practical experience in analysis of intact proteins, purifying and identifying protein-
protein interactions through proximity-based biotinylation or resulting from direct chemical cross-linking;
and enriching/characterizing post-translationally modified peptides using the latest methods. Students
will gain hands-on experience in quantitative proteomic analysis methods: they will be taught label-free
and covalent isotopic-labeling approaches to differentially profile changes in proteomes. Students will
be trained to select and design transitions for targeted peptides and to setup and perform parallel
reaction monitoring mass spectrometry assays to accurately quantify proteins of most interest. They
will also learn how to analyze data-independent acquisition (DIA) data, where broad mass range
tandem mass spectrometry data acquisition allows surveying of all components in a sample. They will
get hands-on experience in de novo interpretation of mass spectrometry data prior to being trained in
database searching software to give a better understanding of the underlying data. For all sections of
the course, a strong emphasis will be placed on data analysis, understanding the reliability of results,
and learning how to convert this data into biological insight. Lecturers will include people from
academia, reagent developers and people working in the pharmaceutical industry, providing a range of
perspectives of the field of proteomics.
The overall aim of the course is to provide each student with the fundamental knowledge and
hands-on experience necessary to be able to design, perform and properly analyze proteomic
experiments. The long-term goal is to train students to identify new opportunities and applications for
proteomics approaches in their biological research and to learn how to integrate these into systems
biology and model organism approaches to human biology and health.

Public health relevance
NARRATIVE Systems biology experiments provide new, revolutionary insights into biological processes improving our understanding of their regulations and thus, laying the foundation for the development of new medical methods and technology. Proteomics represents a suite of methods that yield information about the qualitative and quantitative changes in proteins upon physiological changes, in disease or as a result of treatment, which cannot be gleaned from gene expression data alone. The Cold Spring Harbor Laboratory Proteomics Course ‘jump-starts’ researchers in this complex field by providing hands-on training in experimental methods, thorough exercises in data analysis, and tutorials on the latest technical developments. Thus, the course enables the participants to immediately apply advanced proteomics technologies in their own research. In addition, it provides an opportunity to network with research peers, and to learn the challenges and pitfalls through hands-on access to the latest available equipment. .